CORE--BIOSTATISTICS CORE

The Biostatistics Core will provide statistical and management support and collect home interview data for the Center for Headache Research. Statistical and data management support will include: (1) assistance in design of new projects; computer systems design and maintenance; data management, data entry and data quality review; documentation of data files; provision of files to investigators and training to access; archiving of data files for long-term storage; completion and presentation of statistical analyses; assistance in integrating statistical reports into scientific conclusions and reports; development of new biostatistical methods as needed; presentation of statistical seminars and biostatistical training. (2) data collection and data processing for the home interview using the DIS for Projects 1 and 2.